Functional Biointegration of Bioengineered Salivary Tissues in Irradiated Animal Models

The ultimate goal of this project is to develop a fully functional, implantable human salivary gland for patients
suffering from xerostomia, or chronic dry mouth, subsequent to radiation therapy for head and neck cancer.
Our team recently developed an immunosuppressed, irradiated human-in-miniswine animal model for preclinical
translation of a patented tissue engineered salivary tissue replacement we call the 3D-ST. This large
animal model is suitable for testing cell-based projects designed to restore salivary function that includes both
water secretion and protein/enzyme production needed to initiate digestion and maintain health of the oral
cavity. Complementing this, a radiated nude rat model we developed serves as a useful model for testing
product designs purposed to maximize biointegration including both vasculature and nerve needed for longterm
organ success. Our successful interdisciplinary team includes the Farach-Carson/Wu team at UTHealth,
the Lombaert team in Michigan, and the Swegal surgical team in Pittsburgh. Functioning at three sites, we
developed a demonstrated workflow for experimental success that takes advantage of the unique facilities at
each site. This proposal builds on our exciting supporting data using irradiated models to demonstrate the
ability of transplanted hS/PCs in the 3D-ST to restore salivary secretory function. While our work to date
showed long term (3-4 months) viability of implanted human/stem progenitor cells (hS/PCs) in the 3D-ST
construct in both immunosuppressed miniswine and nude rats, a significant hurdle remains to foster complete,
permanent biointegration of the 3D-ST with the host implant bed. Biointegration of vasculature with salivary
acini is needed to provide nutrition and to supply the fluid component of saliva. Stable innervation is critical for
glandular morphogenesis, achievement of cell polarity for directional secretion, and restoration of autonomic
stimulation of secretion. This proposal builds on our exciting supporting data to encourage transplanted human
hS/PCs to reestablish salivary secretory function and moves our focus from design optimization and implant
viability to successful functional biointegration using our two irradiated models. We hypothesize that both
vasculature and peripheral nerve integration of the 3D-ST can be achieved to stabilize the differentiated
salivary phenotype. The two aims will: 1) use a quantitative scoring system to evaluate biointegration of
vasculature and autonomic nervous system into implanted 3D-STs in irradiated animal models and determine
impact on salivary cell phenotype; and 2) evaluate the ability of the transplanted 3D-ST to restore salivary
function. Successful achievement of these aims will improve existing xenotransplant models for testing a
variety of adult stem/progenitor cell-based therapies to replace exocrine organs and open the door to first-inhuman
trials for relief of xerostomia.

Public health relevance
Project Narrative Head-and-neck cancer patients who undergo radiation therapy often develop a significant side effect of xerostomia, or severe dry mouth, due to a radiation-induced loss of the cells that make saliva. Our therapeutic goal is to recreate a functional salivary gland in the laboratory, using a patient's own cells, and return them to the salivary bed after radiation to restore salivation. Our proposal leverages two irradiated animal models to develop the methodology to achieve full biointegration of the replacement gland such that both blood flow and nervous system interactions are restored to stabilize the functional transplanted new salivary gland.